Career Enhancement Program

PROJECT SUMMARY
The Career Enhancement Program is designed to increase the translational investigator base in the Mayo
Myeloma SPORE by identifying and fostering the early careers of young investigators who have an interest in
multiple myeloma translational research. In particular, this program provides much-needed support for
promising young laboratory or clinical investigators early in their careers so that they can focus their energies
on research projects related to multiple myeloma research. The SPORE CEP provides $50,000 for one year
($90,000 from SPORE funds and institutional support of $50,000 from the Mayo Clinic cancer Center) for 2-3
awards per year. A second year of support is possible based on progress and successful re-competition.
Mayo, as part of its commitment through the Mayo Comprehensive Cancer Center, has agreed to match these
funds. The Career Enhancement Program makes maximal use of the scientific expertise within the Mayo
community. The Career Enhancement Program Committee is responsible for organizing the program and
reviewing research proposals as submitted. During the prior funding period (years 1-5), the SPORE has
supported 12 investigators each for 1 year. All of them remain involved in translational research in myeloma
and related hematologic malignancies, and 10 of 12 are still involved in our SPORE and one is at another NCI
designated Cancer Center.
During the next funding period, the SPORE will maintain:
· a stringent candidate selection system that encourages applications from minorities and women
· comprehensive trainee guidance by a mentor
· support through a scientific mentor group (the Individual Trainee Mentorship Committee) comprised of
investigators with expertise in each trainee’s area of interest
· multi-disciplinary research courses and on-going training activities such as the Multidisciplinary Cancer
Seminar Series and Myeloma Group meetings
· encouragement of collaboration with investigators at all Mayo sites
· opportunities for further research enhancement through the Developmental Research Program and full
Projects.

Public health relevance
PROJECT NARRATIVE The purpose of this program is to support and mentor young investigators at the junior faculty level so that they can become outstanding translational investigators with a primary focus on multiple myeloma. Each individual selected for the project is provided 2 years of salary support ($50,000 per year). Each awardee is expected to spend the 2 years engaged in multiple myeloma translational research under the aegis of a suitable mentor. Again, support for only one of these individuals is being requested by the grant. Developmental funds from the Mayo Comprehensive Cancer Center will.